Lead optimization of hits identified from virtual and experimental screens of multiple industrial libraries DNDi

SUMMARY/ABSTRACT
Neglected tropical diseases (NTDs) are a leading cause of morbidity and mortality, affecting over 1 billion
people worldwide. Given the lack of financial incentive for the for-profit pharmaceutical industry, there is little
translation seen from in vitro drug screening assays into in vivo efficacy studies. We propose to progress hit
compounds, identified from pharmaceutical company compound libraries, through to pre-clinical candidate
status. To achieve this, we have engaged with the Drugs for Neglected Diseases Initiative (DNDi), effectively
aligning ourselves with several partners who bring deep expertise from industry, in medicinal chemistry, drug
metabolism and pharmacokinetics, and from institutions that contribute parasitology experience and a proven
ability to progress drugs for NTDs into the clinic and beyond. Such a project team is singular across the NTD
drug discovery landscape and is a strength of this proposal.
We will accomplish the proposed project goals by focusing our attention on the design of compounds
which meet the Target Product Profile (TPP) for visceral leishmaniasis and Chagas disease. DNDi's Booster
program identifies starting hits through a unique process, involving iterative screening and testing cycles of 7
pharmaceutical company compound libraries. The compound members of each library are well annotated with
known pharmacological activity, and computationally predicted and/or experimentally measured properties
(including aqueous solubility, metabolic stability, in vitro toxicology etc.), enabling the rapid identification of
potential liabilities. This proposal focuses on four chemotypes that emerged from the Booster program that
consist of a large number of validated hits against Leishmania spp. and Trypanosoma cruzi.
The R21 phase will be focused on hit-to-lead optimization and the down-selection of the four chemotypes
to two. We will identify compounds that demonstrate proof-of-concept disease-modifying effects in animal models
of the respective diseases. Further, we will profile those compounds that demonstrate positive effects on
parasitemia in vivo to identify potential liabilities, which will become the focus of the candidate-seeking medicinal
chemistry campaign outlined in the R33 phase.
The R33 phase is focused on the lead-to-preclinical candidate optimization of the prioritized chemotypes.
We are uniquely placed to achieve this goal as we are collaborating directly with DNDi and Celgene Corporation
throughout this project. At the completion of the R33 phase we will deliver a complete data package on two
compounds for each disease (one candidate, one backup) that meets the respective TPP, and which will be
used to justify IND-enabling studies.

Public health relevance
NARRATIVE Visceral leishmaniasis and Chagas disease are both defined as neglected tropical diseases which suffer from a lack of financial investment from the pharmaceutical industry. Yet the current therapeutics are associated with limited efficacy, increasing instances of treatment failure, high cost and long-term toxicity issues. This project will focus on the development of compounds that meet the Target Product Profiles for visceral leishmaniasis and Chagas disease with the view of obtaining pre-clinical candidates that can be progressed by our project partner, DNDi.